Role of nitrate in microbiota ecology

PROJECT SUMMARY/ABSTRACT
The diverse microbial communities, or microbiota, that colonize our barrier sites (e.g., gut, skin, and oral cavity)
broadly impact human health. Whether these impacts are positive or negative depends on the microbiota’s
composition, particularly its ecological balance between health- and disease-promoting microbes (“symbionts”
and “pathobionts,” respectively). Strategies to directly manipulate this balance could therefore unlock the
microbiota’s immense therapeutic potential. Yet, this remains a challenge due to the overwhelming complexity
of microbe-microbe interactions. For host-associated microbiota, polymicrobial interactions are largely driven by
competition and/or cooperation for limited host-derived nutrients, which, depending on their identity/source, can
select for symbionts or pathobionts. In turn, microbiota-derived metabolites can affect the integrity of host
barriers. Due to the central role of metabolites in mediating both microbe-microbe and microbe-host interactions,
the overall goal of my research program is to advance our fundamental understanding of how metabolites shape
microbiota ecology and its varied impacts on host health. Over the next 5 years, my laboratory will work towards
this goal by focusing on the host-derived metabolite nitrate, a microbe-specific nutrient that can selectively induce
the expansion of symbionts and, as a result, promote numerous systemic health benefits (e.g., lowered blood
pressure). Because nitrate is consistently abundant within the host, diverse nitrate-utilizing symbionts
persistently co-colonize individual barrier sites across the body. Despite this, we lack basic knowledge of how
these symbionts interact with each other, with co-residing pathobionts, and with the host to ultimately maintain
local homeostasis at nitrate-rich barrier sites. My future research program will aim to decipher these complex
interactions using the oral microbiota as a tractable model. We will employ microbial genetics (in both oral
symbionts and pathobionts), genomic tools (most notably, high-throughput transposon mutant growth profiling,
or Tn-seq), both simplified (2-species) and complex microbial communities (ex vivo oral microbiota cultures),
and both in vitro (biofilm) and in vivo (mouse) models to define key mechanisms by which nitrate governs
microbiota ecology and its reciprocal impacts on the host. Long-term, our vision is that this research will lay the
groundwork for the development of novel microbiota-directed therapies that can precisely control the microbiota’s
composition to promote human health.

Public health relevance
PROJECT NARRATIVE Host metabolic products (metabolites) that can serve as microbial nutrients play a critical role in governing the ecology of the microbiome, which in turn has major consequences for human health. The microbe-specific nutrient and abundant host metabolite nitrate supports a diversity of health-promoting microbes across the body, but how these microbes interact with each other, co-residing disease-promoting microbes, and the host to ultimately promote human health remains poorly defined. Using nitrate as a model, this project will elucidate fundamental mechanisms by which host metabolites mediate complex microbiome-host interactions.